Bone age determination for the 21st Century: Using AI to broaden and diversify a 60-year-old gold standard and overcome reader bias

Project Summary / Abstract
Bone age (BA) is a measure of maturation of a child’s skeleton, and, as such, a key clinical indicator of
growth used by pediatricians and pediatric endocrinologists. As a person’s body ages, from birth through
childhood, puberty, and adulthood, the size and shape of the bones of the skeleton change. Growth plates,
initially wide open, fuse progressively in childhood. The BA is meant to be the “average” age at which the
skeleton reaches a certain degree of maturation. In combination with other measures, it can be used to predict
future adult height and detect possible growth disorders or abnormal pubertal maturation. The estimation of BA
with a radiological image of the left hand and wrist describes the degree of maturation of a child’s skeleton.
The most commonly available standards for the BA estimation, such as the Greulich and Pyle (G&P) Atlas
(1959) and the Tanner-Whitehouse method, involve visual inspection of X-ray images of the person’s left hand
and wrist, followed by its comparison with the set of reference images. This manual inspection is not only time-
consuming, but subjective, and the estimation among radiologists may vary depending upon experience /
expertise. Moreover, the data collected in these approaches is outdated: the current population of the United
States has been much reshaped in the last 60 years, due to a larger number of children of international
ancestry and a nutritional environment, particularly during the COVID pandemic, that has resulted in an obesity
pandemic that affects the growth and rate of physical maturation of children. Thus, there is a need to renovate
these bone age standards such that the reference is representative of the current population and develop an
AI-assisted system for the accurate prediction of bone age. Moreover, the research team for the proposed
project will develop an adjustment factor to incorporate the BMI Z-score for more clinical relevance of the AI-
assisted outcome. The proposed technical approach is three-pronged. Specific Aim 1 is to establish a
database for BA assessment in children that addresses racial and ethnic disparities and reduces spacing
between available standards. Specific Aim 2 is to develop and validate an AI-assisted classification system for
BA readings from the X-ray images. Finally, Specific Aim 3 is to enhance BA determination by an adjustment
factor reflecting the impact of BMI Z-score on skeletal maturation. In support of all three aims, a web designer
will build and deploy a web application capable of incorporating the AI algorithm for the adjusted Bone Age
determination with qualitative data provided by users.

Public health relevance
Project Narrative Bone age, a measure of maturation of a child’s skeleton and, as such, a key clinical indicator of growth used by pediatricians and pediatric endocrinologists, is obtained as the result of a visual match with one of the standards compiled in the Greulich and Pyle Atlas (1959), a gold standard clinical atlas that provides a set of radiographic data sampled from children at different ages. This clinical tool has several limitations that affect the accuracy of the BA assessment and is not representative of the ethnic distribution and BMI of children today. We propose to revolutionize bone age assessment by linking bone age to clinical parameters that are relevant to children of varied ancestry and a broad range of BMI, while leveraging AI-assisted readings to facilitate the adoption of new ethnic and BMI adjustment factors for more accurate bone age determination.